Bioinformatics Strategies for Multidimensional Brain Imaging Genetics

DESCRIPTION (provided by applicant): Today's generation of multi-modal imaging systems produces massive high dimensional data sets, which when coupled with high throughput genotyping data such as single nucleotide polymorphisms (SNPs), provide exciting opportunities to enhance our understanding of phenotypic characteristics and the genetic architecture of human diseases. However, the unprecedented scale and complexity of these data sets have presented critical computational bottlenecks requiring new concepts and enabling tools. To address these challenges, using the study of Alzheimer's disease (AD) as a test bed, this project will develop and validate novel bioinformatics strategies for multidimensional brain imaging genetics. Aim 1 is to develop a novel bi- multivariate analysis strategy, S3K-CCA, for studying imaging genetic associations. Existing imaging genetics methods are typically designed to discover single-SNP-single-QT, single-SNP-multi-QT or multi-SNP-single- QT associations, and have limited power in revealing complex relationships between interlinked genetic markers and correlated brain phenotypes. To overcome this limitation, S3K-CCA is designed to be a sparse bi- multivariate learning model that simultaneously uses multiple response variables with multiple predictors for analyzing large-scale multi-modal neurogenomic data. Aim 2 is to develop HD-BIG, a visualization and systems biology framework for integrative analysis of High-Dimensional Brain Imaging Genetics data. Machine learning strategies to seamlessly incorporate valuable domain knowledge to produce biologically meaningful results is still an under-explored area in imaging genetics. In this aim, we will develop a user-friendly heat map interface to visualize high-dimensional results, adjust learning parameters and strategies, interact with existing bioinformatics resources and tools, and facilitate visual exploratory and systems biology analysis. A novel imaging genetic enrichment analysis (IGEA) method will be developed to identify relevant genetic pathways and associated brain circuits, and to reveal complex relationships among them. Aim 3 is to evaluate the proposed S3K-CCA and IGEA methods and the HD-BIG framework using both simulated and real imaging genetics data. This project is expected to produce novel bioinformatics algorithms and tools for comprehensive joint analysis of large scale heterogeneous imaging genetics data. The availability of these powerful methods is critical to the success of many imaging genetics initiatives. In addition, they can also help enable new computational applications in other areas of biomedical research where systematic and integrative analysis of large-scale multi-modal data is critical. Using AD as an exemplar, the proposed methods will demonstrate the potential for enhancing mechanistic understanding of complex disorders, which can benefit public health outcomes by facilitating diagnostic and therapeutic progress.

Public health relevance
Public Health Relevance (Narrative) Recent advances in multi-modal imaging and high throughput genotyping techniques provide exciting opportunities to enhance our understanding of phenotypic characteristics and underlying genetic mechanisms associated with human diseases. This proposal seeks to develop new bi-multivariate machine learning models and novel enrichment analysis methods, coupled with a visualization and systems biology framework, for integrative analysis of high-dimensional brain imaging genetics data. The methods and tools are developed and evaluated in an imaging genetic study of Alzheimer's disease, and can also be applied to many other disorders to improve public health outcomes by facilitating diagnostic and therapeutic progress. __SpecificAimsTextDelimiter__ Specific Aims Recent advances in brain imaging and high throughput genotyping techniques enable new approaches to study the influence of genetic variation on brain structure and function. Rich multimodal neuroimaging phenotypes coupled with high density genotyping data are, or will soon be, available from large-scale landmark studies such as the NIH Alzheimer's Disease Neuroimaging Initiative (ADNI) and Human Connectome Project as well as numerous major collaborative investigations in the US and around the world (e.g., many participants of the Enhancing Neuro Imaging Genetics through Meta Analysis (ENIGMA) Network and the Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE) Consortium). For example, ADNI is an ongoing multi-year public-private partnership to test whether serial magnetic resonance imaging (MRI), positron emission tomography (PET), genetic factors such as single nucleotide polymorphisms (SNPs), other biological markers, and clinical and neuropsychological assessments can be combined to measure and predict the progression of mild cognitive impairment (MCI) and early Alzheimer's Disease (AD). Given the availability of genome-wide SNP data and repeat structural and functional neuroimaging data as part of this initiative, ADNI provides an ideal test bed for studying bioinformatics algorithms for large scale imaging genetics studies. The unprecedented scale and complexity of these data sets have presented critical computational challenges for relating genome-wide genetic data with large-scale quantitative traits (QTs) such as multidimensional neuroimaging phenotypes. This project is proposed to address these challenges with the following three aims. Aim 1: A novel bi-multivariate analysis method for studying imaging genetic associations. Many existing imaging genetics studies apply massive univariate analysis strategies to identify single-SNP-single-QT associations, while studies that employ multivariate methods typically focus on finding single-SNP-multi-QT or multi-SNP-single-QT associations. These paradigms have limited power in revealing complex relationships between interlinked genetic markers and correlated brain phenotypes. To overcome this limitation, we propose a novel bi-multivariate learning strategy that simultaneously uses multiple response variables with multiple predictors for analyzing multi-modal and heterogeneous "neurogenomic" data. We will develop a novel sparse machine learning framework for the analysis of genome-wide association results across a large number of brain structural and functional phenotypes derived from MRI and PET imaging of the whole brain. Aim 2: A visualization and systems biology framework for identifying and interpreting imaging genetic associations in a biologically meaningful fashion. How machine learning strategies can be strategically integrated with prior critical domain knowledge to produce biologically meaningful and important findings is still an under-explored area in imaging genetics. In this aim, we will develop a user-friendly heat map interface to visualize high-dimensional research results, adjust learning parameters and strategies, interact with existing bioinformatics resources and tools, and facilitate visual exploratory and systems biology analysis. The novel method proposed in Aim 1, coupled with other widely used imaging genetics methods, will be implemented and included as learning components in our system. We will integrate the learning results with knowledge about gene ontology, biochemical pathways, and structural and functional brain atlases to study imaging genetic associations in the context of systems biology. A novel enrichment analysis method will be developed for imaging genetics applications to identify relevant genetic pathways and associated brain circuits, and to reveal complex relationships among them. Aim 3: Evaluation and validation on both simulated data and real imaging genetics cohorts. We will compare the proposed methods with the existing multivariate approaches such as parallel ICA and sparse regression models. We will use high-dimensional and multi-modal data from the ADNI cohort as the basis to create realistic simulation of imaging genetic data with known ground truth for evaluation and validation of the proposed methods. We will also apply these imaging genetic methods to the ADNI cohort, as well as to other imaging genetic cohorts available to us for confirmation and replication. This project is expected to produce novel bioinformatics algorithms and tools for comprehensive joint analysis of large scale heterogeneous imaging genetics data. The availability of these powerful methods is critical to the success of many imaging genetics initiatives like ADNI. In addition, they can also help enable new computational applications in many other biomedical research areas where systematic and integrative analysis of large-scale multi-modal data is of interest. Using AD as an example, the proposed methods will be demonstrated to have considerable potential for enhancing mechanistic understanding of complex disorders, and thus be expected to impact biomedical research in general and benefit public health outcomes.